High parameter fluorescence activated cell sorter

Project Summary/Abstract
The Versiti Blood Research Institute (VBRI) is an academic hematology research center located in Milwaukee,
WI. The VBRI Flow Cytometry Core serves the needs of scientists at the VBRI, the Medical College of Wisconsin
(MCW), and the Children’s Research Institute (CRI), three research-heavy institutions assembled on the
Milwaukee Regional Medical Campus (MRMC). Currently, a heavily oversubscribed Cytek Aurora in the CRI is
the only high parameter cell sorter on the MRMC. The VBRI’s 15-year old FACS Aria can no longer support the
sophisticated sorting needs of many MRMC users and will need to be replaced in anticipation of BD’s
discontinuation of servicing the product line. To address these deficiencies, we are requesting funds to purchase
a Becton Dickinson Symphony S6 SE, a 5-laser, 49-detector cell sorter. The Symphony S6 matches the
Symphony A5 SE analyzer purchased by VBRI in 2022, allowing for seamless transfer of multi-color panels from
analysis to sorting. The research projects of our nine Major and eight Minor NIH-funded users require high
parameter cell sorting to accomplish their goals. Using the Symphony A5 SE analyzer, these investigators have
acquired valuable expertise in spectral flow cytometry, and the acquisition of a Symphony S6 will enable them
to overcome critical roadblocks in their research. VBRI research will broadly benefit from this new instrument. In
immunology, development of a B cell therapeutic for multiple sclerosis, the delineation of B cell involvement in
heparin-induced thrombocytopenia as well as clarifying the mechanism of thrombotic complications in COVID-
19 all require access to high parameter sorting, using panels already established on the Symphony A5 SE. Major
Users focused on hematologic malignancies require rapid access to a multi-parameter cell sorter to isolate rare
cell populations from primary leukemia samples that can arrive any time. A signature program studying the role
of the glycome in hematopoiesis is critically dependent on the Symphony S6’s increased number of channels. In
thrombosis and hemostasis, studies on cellular integrins, kindlin signaling in neutrophils and platelets, and the
pathophysiology of fetal/neonatal alloimmune thrombocytopenia will all heavily use the Symphony S6. Moreover,
the Symphony S6 will overcome critical bottlenecks for MCW researchers studying the role of exosomes in
ovarian cancer, chronic pain in Fabry and sickle cell disease, gamma herpesvirus associated B-cell lymphomas,
immune response to radiation exposure and type I diabetes. FACS is an integral part of the workflow of most
VBRI faculty and many researchers at MCW and CRI. Currently available high parameter (>20) sorting capacity
is extremely limited, slowing progress on NIH-funded research. Even lower parameter sorting capacity is
becoming limited on the MRMC as BD FACS Aria instruments are approaching end of lifespan. The Symphony
S6 will provide essential high parameter sorting capacity for several NIH-funded projects, and dramatically
accelerate progress on others. Ease of panel transfer, economic use of precious samples, and complementarity
to existing instrumentation will expedite research progress to ascertain a high return on investment.

Public health relevance
Project Narrative Funds are requested to purchase a fluorescence activated cell sorter that will allow scientists at the Versiti Blood Research Institute, the Medical College of Wisconsin, and Children’s Research Institute to study cells involved in autoimmune disease, viral infection (including COVID-19), cancers (especially those of the blood), blood clotting and bleeding disorders, type I diabetes, radiation injury, and pain in sickle cell disease. This multi- parameter cell sorter is a critical tool for scientists to develop new treatments and cures for these diseases.